Biostatistics & Bioinformatics Core

Biostatistics and Bioinformatics Core Abstract
The primary goal of the Biostatistics and Bioinformatics Core is to provide a full set of statistical and bioinformatic
services to the P01 projects to enhance the project’s ability to address key questions about the mechanisms of
bladder cancer’s development and its therapeutic vulnerabilities to preventive and interventive therapy. The
Biostatistics and Bioinformatics Core will serve as a comprehensive, multilateral quantitative resource to all
Project investigators and other Cores for hypothesis refinement, the design of clinical, translational, and basic
science experiments, data acquisition and management, comprehensive quality control, development and
application of innovative and state-of-the-art statistical methodology, statistical and bioinformatic analyses,
proper data interpretation, and publishing results through abstracts, papers, and presentations. The Biostatistics
and Bioinformatics Core will collaborate with the Project and Core Leaders to accomplish the following specific
aims: Aim 1: To provide guidance in the design and conduct of clinical trials, in vitro and in vivo experiments,
including genomics, epigenomics, transcriptomics, single cell sequencing, and spatial transcriptomics to the
P01 projects; Aim 2: To provide biostatistical and bioinformatic modeling and data analyses needed by the
Projects and other Cores to achieve their Specific Aims; Aim 3: To generate statistical reports for all Projects
and assist Project investigators in publishing scientific results, ensuring analyses are properly interpreted and
accurately communicated. By providing research expertise and logistic support to the Projects’ analytical
activities, this Core will contribute to the professional, efficient, and rigorous use of the data generated by each
Project and will be critical to the success of basic and translational research in bladder cancer and the overall
P01.

Public health relevance
Biostatistics and Bioinformatics Core Narrative The primary goal of the Biostatistics and Bioinformatics Core is to provide a full set of statistical and bioinformatics services to the P01 projects which will enhance the abilities of projects to address key questions in mechanisms of bladder cancer development and its therapeutic vulnerabilities to preventive and interventive therapy. By providing research expertise and logistic support to data analytic activities within each project, the Biostatistics and Bioinformatics Core will contribute to a professional, efficient, and rigorous use of the data generated by each project and will be critical to the success of basic and translational research in bladder cancer and the overall P01.